Regulatory Network Differences/Diverse Tumor Subtypes/Design Combinatorial Therap

This subproject builds on recent experimental and computafional work in the Sander lab to further develop a systematic approach to the derivation of predictive computational models for cancer cells and tissues. This systems biology approach focuses on highly constrained (parameter-sparse) computational models derived from a series of systematic drug-drug perturbation experiments with rich observational readout. This approach (CoPIA - combinatorial perturbation-interaction analysis) is thus at an optimal methodological point between purely statistical network models on the one hand (that typically do not capture the physico-chemical dynamics of biological processes) and large differential equation models of biochemical kinefics (that typically lack sufficient parameters to realistically simulate cell biological processes). The project will start with detailed perturbafion experiments and modeling in model systems for glioblastoma subtypes and for drug resistance in melanoma (synergy with sub-project 1). A key focus of the project will be in pushing fon/vard the applicafion of advanced measurement technologies and the development of novel, more efficient algorithmic approaches for network model construction ('reverse engineering') and opfimization. Work on both of these tracks has already been initiated with one-year seed funding from the MSKCC Experimental Therapeufics Center (ETC). The Sander group has established a laboratory in the Zuckerman Research Center (2008) and implemented opfimal growth conditions and drugdrug perturbafion protocols for both glioblastoma-derived tumorspheres and melanoma cell lines. Pilot experiments for high-throughput data acquisifion using reverse phase protein arrays (RPPA, collaborafion with Gordon Mills, MD Anderson) are in progress in June 2009. Algorithmic development has begun to focus on several promising routes. One challenge is to scale up model construction to systems with several hundred or more nodes, corresponding to a very large number of model configurations. We are currently exploring methods of statistical physics to make this process manageable, with the much more efficient derivation of probability distribufions over discrete edge values rather than more expensive enumerafion of sets particular solufions. As an alternative, we are exploring other algorithmic approaches, such as modular decomposition, starting solutions from correlafion analysis and genefic opfimizafion algorithms. In addifion, we have designed an approach to incorporate secure prior knowledge into the modeling process. Confinuous development of the computational approaches is a key thread running through all of the Specific Aims. The ulfimate clinical aim of this sub-project is the design of effecfive combinatorial therapies that address diversity in tumor subtypes and differences in therapy-sensitive versus resistant tumors, validation of the combinatorial drug protocols in cell lines and mouse models, and the design of clinical trials.